Regional Oncology Research Center (LLMs for Unstructured Data Extraction)

Abstract
Artificial intelligence (AI) has the potential to revolutionize healthcare by leveraging clinical data to advance
research and improve oncology practice. Within free-text pathology reports, crucial information about primary
cancer diagnoses and evolving molecular features is embedded. Extracting and interpreting this information
accurately is essential for determining cancer stage, which plays a decisive role in prognosis and guiding clinical
management. Although natural language processing (NLP) techniques have been applied to extract focused
information from pathology reports, there is still a need for adaptable, generalizable, and interpretable strategies
to enhance clinical data abstraction. To address this need, we propose a multidisciplinary approach to develop
an integrative clinical information extraction pipeline. This work aims to improve, assess, and enhance the
abstraction of relevant features of pathological diagnosis from pathology reports by leveraging large language
models.
Our research design involves several steps. First, we will establish a diverse and equitable cohort of patients
from our Cancer Registry and collect free-text pathology reports, along with structured clinical data obtained from
the Johns Hopkins School of Medicine Precision Medicine Analytics Platform (PMAP) Data Commons. Next, we
will employ an information extraction platform to identify pathological features from the reports. This platform will
utilize a suite of models, including BERT-like models, GPT-3.5, and GPT-4, provided by Microsoft, specifically
designed for identifying key cancer attributes. Subsequently, we will evaluate the output of individual models
using the CASPER interactive model development framework, enhancing and refining the results through
heuristics and weak supervision. The augmented model output will be presented through a web-based user
interface, allowing expert curators to provide further input. We will then compare the effectiveness of each
CASPER-augmented model and its derived pathological features against the established gold standard
annotations from the Cancer Registry. Finally, we will enhance the GPT-based language models based on the
assessment, curation, and comparison process, employing prompt engineering techniques to improve
performance and mitigate bias.

Public health relevance
Narrative Innovation in oncology is heavily dependent on identification and extraction of relevant data elements from patient pathology reports. Current approaches require high manual effort or specialized model building which are inefficient. We propose a multidisciplinary approach to leveraging Large Language Models (specifically Generative Pretrained Transformers) to extract relevant patient data elements from pathology reports and compare to results from expert-in-the-loop and a BERT model.